Harnessing PET to Study the In Vivo Fate and Health Effects of Micro- and Nanoplastics

ABSTRACT
CANDIDATE: The candidate is a postdoctoral fellow in the laboratory of Dr. Zeglis at Hunter College of CUNY.
Her proposed research will provide a strong foundation for independent research career following the K99 phase
of this grant. Her long-term career goal is to establish a robust program in environmental pollution research
utilizing molecular imaging. To achieve this, she has developed a career plan that will (1) broaden her technical
and scientific skills (2) strengthen her presentation and communication skills, and cultivate her professional
relationships, (3) enrich her mentoring skills, and (4) prepare her for the transition to independence.
RESEARCH: The proliferation of micro- and nanoplastics in the environment is increasing at an alarming rate.
Micro- and nanoplastics have been found to be persistent and ubiquitous pollutants in a variety of environments,
including sea water, fresh water, soil, sewage, and air. In light of this harrowing phenomenon, the evaluation of
the possible health effects of microplastic (<5 mm) and nanoplastic (<100 nm) pollutants has emerged as an
unmet scientific need. The over-arching goal of this investigation is to study the biodistribution and health effects
of micro- and nanoplastics in mammals using a sensitive and quantitative molecular imaging technique: positron
emission tomography (PET). The exquisite sensitivity of PET is major advantage of this strategy, as it will
facilitate the non-invasive tracking of micro- and nanoplastics at environmentally relevant concentrations. The
specific aims are: 1) To determine the bioaccumulation and bioretention of radioplastics in mice after pulmonary
and oral exposure, 2) To quantify the bioaccumulation and bioretention of radioplastics in pregnant mice after
oral and pulmonary exposure, and 3) To quantify the pro-inflammatory effects of micro- and nanoplastic exposure
via non-invasive approaches.
ENVIRONMENT: Hunter College is known for its highly collaborative environment to facilitate interdisciplinary
research efforts such as those proposed in this application. The candidate is mentored by Dr. Zeglis, a
recognized inorganic radiochemist with groundbreaking work in preclinical investigations of
radiopharmaceuticals. In addition, she is co-mentored by Dr. Stapleton, an environmental toxicologist who has
done pioneering and innovative contributions to the plastic research. Hunter College provides a rich set of
collaborative, technical and scientific resources to execute the research and career development proposed here.

Public health relevance
PROJECT NARRATIVE In this investigation, we will use nuclear imaging to study the in vivo behavior and health effects of polystyrene micro- and nanoplastics in mammals under environmentally relevant concentrations. Determining the biodistribution, biokinetics, and bioretention of these materials will shed light upon the mechanisms of their toxicity and has the potential to impact decision-making on the remediation of plastic pollutants as well as the exposure of workers and the public to these materials.